The role of Lamp1 and lipid transport in the regulation of vesicle identity

Aging-associated diseases are an increasing socio-economic burden despite efforts to improve
healthspan. Pathologies that cause degeneration of the nervous system are particularly
devastating, and in many cases are associated with decline in proteostasis and lysosomal
malfunction. Prime examples are Parkinson and Alzheimer’s disease that are characterized by
accumulation of insoluble protein aggregates that lead to neuronal decay. Lysosomal degradation
of cytoplasmic components depends on proper transport of hydrolases from the Golgi to
lysosomes where they encounter the acidic environment necessary for their activation.
Lysosomes are also important regulatory hubs that integrate nutritional signals and participate in
lipid metabolism, and these diseases are associated with alterations in lysosomal pH and
accumulation of lipids, particularly cholesterol in the lysosome.
We have recently characterized Drosophila Lamp1, a bona fide homolog of the mammalian
LAMP1/2 proteins with partially redundant roles in autophagy and cholesterol assimilation.
Drosophila Lamp1 localizes to late endosomes and lysosomes and is, in contrast to Lamp1/2, not
required for development, autophagy, or viability; however, males have a reduced mean lifespan.
Critically, Lamp1 deficiency results in an increase in the number of acidic organelles in the fat
body, strongly suggesting defects in the regulation of the pH of the endolysosomal system.
Furthermore, Lamp1 mutant larvae have elevated levels of sterols and diacylglycerols, indicating
functions of Lamp1 in lipid transport beyond sterols, that we are in the unique possibility to assess
in the absence of confounding autophagy defects.
This proposal will identify the connection between Lamp1 function, endolysosomal
acidification, and lipid metabolism, and investigate how these processes are connected to
neurological disorders. Because altered endolysosomal regulation contributes to many aging-
related diseases, our research will significantly advance our understanding of how dysfunction of
endolysosomal system underlies disease, ultimately leading to the development of novel
treatment strategies to improve healthspan.

Public health relevance
Project narrative Caring for an ever aging society represents an increasing social and economical burden and continuing efforts are required to improve health during the course of life. Getting old increases the chances of succumbing to devastating diseases including cancer, and dementias such as Alzheimer’s disease and Parkinson affecting millions of people in the US. These diseases are caused by an increase of damaged and non-functional proteins at old age. We have established an animal model to address the role of decreased pH in the organelles responsible for the degradation of proteins in the fruitfly Drosophila. We are thus in a position to find out how an increase in toxic proteins leads to neurodegeneration in a fly model of Parkinson with the ultimate goal to identify novel treatment options to improve life at old age.